The role of astrocytes in emergence from volatile anesthetics

Project Summary
Our overarching goal is to define the molecular and cellular mechanisms underlying the actions of
volatile anesthetics (VAs). Our objective in the studies proposed here, which represent the next step in
pursuing this goal, is to mechanistically define the functions of astrocytes that underly their involvement in the
process of emergence from anesthesia with VAs. We hypothesize, based on substantial recent and preliminary
data, astrocyte mitochondrial electron transport chain (ETC) function supports normal emergence through
maintenance of astrocyte calcium signaling, gliotransmitter release, and metabolic support to neurons. We
further hypothesize that specific, spatially defined, populations of astrocytes within the central nervous system
(CNS) drive emergence through their local support of neuronal synapses involved in emergence.
Our experiments will take advantage of pure primary astrocyte cell culture, a mouse model for cell-specific
disruption of mitochondrial function through cre-mediated excision of the ETC complex I protein Ndufs4, and
stereotactic microinjection targeted viral delivery of an astrocyte promoter driven cre-recombinase to enable
brain region-specific disruption of Ndufs4 specifically in astrocytes. These models will allow us to characterize
the astrocyte functions impacted by VAs and the population of astrocytes involved in emergence. Specifically,
they will allow us to: i) define the effects of VAs on astrocyte calcium signaling and mitochondrial function, and
the mechanistic links between the two, in vitro; ii) characterize the effects of VAs on astrocyte gliotransmitter
release; iii) characterize the impact of VAs on astrocyte metabolites which support neuronal function; iv) define
the astrocyte population, defined by region, responsible for supporting emergence from anesthesia with VAs.
Ultimately, this work will greatly advance our understanding of the mechanisms of VA activity and the process of
emergence.
Relevance
Despite their prevalence, the precise targets of VAs, and the mechanisms underlying their pleiotropic effects,
are largely undefined. Emergence is a daily occurrence for thousands of patients, but the process of emergence
is poorly understood. Delays in emergence are associated with anxiety, confusion, resistive activity, delays in
the operating room, increased risks of injury, and significant medical costs. If the mechanisms of emergence can
be resolved, it may be possible to develop strategies for active promotion of recovery of consciousness.

Public health relevance
Project Narrative The mechanisms of emergence, or ‘waking up’, from general anesthesia with volatile anesthetics are poorly understood, and delays in emergence are associated with anxiety, confusion, operating room delays, and increased medical costs. If the mechanisms underlying emergence can be resolved, it may be possible to develop strategies for active promotion of recovery of consciousness. The aim of the experiments in this proposal, which are supported by significant preliminary data, is to define the role of astrocytes, a cell in the brain that supports neuron function, in regulating emergence.